Assessing biomarkers of intestinal fibrosis and inflammation in Crohn's Disease via an endoscopic imaging catheter

ABSTRACT STATEMENT The Abstract has not changed since the original R01 awarded application.

Public health relevance
NARRATIVE STATEMENT The Narrative has not changed since the original R01 awarded application.